Advancing Thyroid Cancer Diagnostics with AI-enhanced Multimodal Optical Histopathology

PROJECT SUMMARY/ ABSTRACT
The increasing incidence of thyroid cancer worldwide is partly fueled by enhanced detection of smaller nodules
through imaging techniques like ultrasound, computed tomography (CT), and magnetic resonance imaging
(MRI), leading to overdiagnosis of low-risk cancers and benign thyroid conditions. Papillary thyroid carcinoma,
the most prevalent type of thyroid cancer, presents lymph node metastasis (LNM) in 60 to 70% of cases,
increasing the risk of local recurrence, distant metastasis, and mortality. Fine needle aspiration (FNA), the
primary diagnostic method, yields indeterminate results for 10 to 20% of nodules, of which 20 to 30% of nodules
may be malignant. Such uncertainty results in repeat biopsies, costly molecular tests, or unnecessary surgeries,
causing increased healthcare costs, reduced quality of life, and emotional distress. Core needle biopsies (CNB)
are suggested for indeterminate FNA findings. However, CNB is also prone to sampling errors, not suitable near
critical structures, and both FNA and CNB are time-consuming procedures and can alter tissue morphology.
Given the prevalence of false positives, complications arising from indeterminate diagnoses, prolonged analysis
periods, and sampling challenges in thyroid cancer detection, there is a pressing demand for a more effective
diagnostic solution. Our proposal introduces an AI-augmented, multimodal, label-free nonlinear optical
microscopy system that incorporates coherent anti-Stokes Raman scattering microscopy (CARS), second
harmonic generation microscopy (SHG), and two-photon autofluorescence microscopy (TPAF). This innovative
system aims for rapid and precise diagnosis of thyroid cancer and LNM. By eliminating the need for external
dyes, the label-free technique streamlines the diagnostic process and minimizes complications. This combination
of imaging modalities with AI augmentation offers detailed and complimentary subcellular morphological and
biochemical information, enhancing our understanding of biochemical composition of thyroid nodules and lymph
nodes, facilitating identification of malignancy markers more accurately, and significantly improving diagnostic
accuracy.
In addition, we plan to develop a compact, portable, AI integrated label-free microendoscope for clinical
translation, designed to fit within a core biopsy needle, for differentiating between cancerous and normal tissues
and detecting LNM without tissue excision. Validated through studies on ex vivo human tissues and in vivo
porcine models, this device promises to transform thyroid cancer diagnosis by serving as a virtual histopathology
tool, enabling real-time, label-free imaging and addressing the drawbacks of FNA and CNB, such as
overdiagnoses, indeterminate diagnoses, and false positives, without tissue excision or harm to critical adjacent
structures. Upon project completion, we anticipate delivering an AI-enhanced, label-free benchtop system for
testing in outpatient clinics, capable of imaging FNA samples for rapid and precise diagnosis within minutes, and
a comparable label-free microendoscope as a potential optical histopathology device to facilitate near real-time
cancer diagnosis without tissue excision.

Public health relevance
PROJECT NARRATIVE The proposed project offers substantial public health advantages by potentially transforming the diagnosis of thyroid cancer and lymph node metastasis. By creating an AI-powered multimodal, nonlinear, and label-free optical microscopy imaging system, diagnosis can be accelerated compared to current histopathology or cytopathology methods. Expanding the benchtop microscopy system into a label-free multimodal microendoscope enables virtual histopathology without tissue excision, facilitating near real-time accurate diagnosis.